EFFECT OF DIETARY SODIUM ON PREGNANCY INDUCED HYPERTENSION

To determine whether dietary sodium restriction leads to more rapid resolution of pregnancy-induced hypertension than bedrest alone. Uses the CORE laboratory and CDMAS only.